Role of Autophagy in Regulating Cytokine-Induced Macrophage Cell Death and Systemic Inflammatory Responses

PROJECT SUMMARY
The goal of this Mentored Clinical Scientist Research Career Development Award (K08) is to provide a 5-year
training pathway for Anthony Orvedahl, MD, PhD, to become an independent investigator. Dr. Orvedahl obtained
the MD, PhD degree in the Medical Scientist Training Program at the UT Southwestern Medical Center, where
he studied the role of autophagy in innate antiviral immunity. After training in Pediatrics and Infectious Diseases
at St. Louis Children's Hospital/ Washington University, he joined the lab of Herbert “Skip” Virgin, MD, PhD, who
is a renowned expert in antiviral immunity. Gary Silverman, MD, PhD, who will serve as the primary Co-Mentor,
is a practicing physician-scientist in Neonatology with recognized expertise in mechanisms of cell death. In his
preliminary work using genome-wide CRISPR screening, Dr. Orvedahl identified an important role for autophagy
genes (including Atg5) in regulating IFNγ-induced cell death. A suppressor CRISPR screen on an Atg5-deficient
background revealed the TNF pathway as a mediator of the hypersensitivity to cell death. However, TNF was
insufficient on its own to trigger cell death, which indicated one or more additional IFNγ-induced factors contribute
to TNF-induced death. Preliminary work suggests that one of these factors is the IFNγ-induced mitochondrial
enzyme, immune regulated gene 1 (IRG1). Importantly, mice with myeloid cell-specific autophagy gene-
deficiency exhibited markedly decreased survival in a TNF-induced model of shock. However, the specific type
of cell death induced by IFNγ in combination with TNF, the mechanism of IRG1 and its enzymatic product
itaconate, and the in vivo role of these factors during TNF-induced shock remain unclear. The proposed studies
to address these questions in this K08 will require in-depth analyses of cell death and mitochondrial homeostasis
using multiple microscopic, flow cytometric, and biochemical techniques. Washington University School of
Medicine provides an ideal environment to pursue the training plan outlined in this proposal. The Department of
Pediatrics has a longstanding commitment and track record of training independent physician-scientists. Dr.
Orvedahl has established successful collaborations related to this project, and interacts frequently with
investigators in the departments of Pediatrics and Pathology/ Immunology. An oversight committee has been
formed that includes advisors with expertise in immunometabolism, autophagy in intestinal inflammation, protein
biochemistry, and macrophage immune responses. The training plan incorporates technical workshops, as well
as formal coursework on grantsmanship, which will facilitate transition to independence towards the end of the
award period. The combination of mentorship, institutional resources, and focused training activities offer an
unparalleled opportunity to achieve the goals of this proposal. The immediate research goals described herein
are to: 1) investigate the mechanism of autophagy in protection against cytokine-induced macrophage cell death;
2) evaluate the role of a novel factor, IRG1, that links mitochondria to the mechanism of cell death; and 3) apply
these findings in vivo to a model of fatal TNF-induced shock.

Public health relevance
PROJECT NARRATIVE Robust immune responses must be delicately balanced to ensure pathogen clearance while avoiding damage to the host, as over-exuberant cytokine activity can lead to fatal diseases such as sepsis. Autophagy is a highly evolutionarily conserved cytosol-to-lysosome degradative pathway that plays diverse roles in immunity, and in preliminary studies described in this proposal was found to protect myeloid cells against cytokine-induced cell death and mice from fatal TNF-induced shock. The goal of this K08 proposal is to provide a 5-year training plan for the PI, Dr. Anthony Orvedahl, to develop the skills and resources necessary to establish a robust independent research program aimed at deciphering the mechanisms of pro-survival autophagy and the role of a novel candidate mediator of cytokine-induced death, IRG1.